Enhancing Safety and Efficacy of Stem-Cell Derived Islet Transplantation using CRISPR-Mediated Genome Engineering

Project Summary/Abstract
Over the last decade, pancreatic islet transplantation has become a consistent and effective minimally invasive
approach to restore normoglycemia in patients with type 1 diabetes1. Despite recent advances, widespread
application has been limited by several barriers, including (1) poor survival and engraftment of islets following
infusion into the portal vein of the liver, secondary to instant blood-mediated inflammatory reaction (IBMIR) and
ischemia, (2) an inability to consistently achieve long-term insulin independence despite multiple infusions of
islets from up to three donors, (3) a critical shortage of donor islets available for transplant, and (4) the inability
to retrieve the graft in real time in case of adverse events. This proposal aims to address all four of these barriers
utilizing genome-engineered stem-cell-derived beta cells. In contrast to cadaveric islets, human pluripotent stem
cell-derived beta (SC-beta) cells represent a replenishable source of replacement beta cells2–7. Improving
engraftment of SC-beta cells in an extra-hepatic site, together with engineering safety switches to delete any
implanted SC-derived cells that display aberrant growth, will render this therapy safer and more effective,
bringing benefit to more patients. Our prior work has shown that co-transplantation of parathyroid gland tissue
with adult donor islets improves survival and engraftment at a retrievable intramuscular injection site in mice. We
hypothesize that the secreted factors uniquely expressed by parathyroid gland may improve islet survival and
vascularization. However, to overcome the limitations of parathyroid gland donor tissue availability and
procurement, these effective factors will be introduced into stem-cell-derived beta cells using genome
engineering strategies to improve engraftment and angiogenesis. Moreover, because the potential for outgrowth
or oncogenesis is a major safety concern with any stem-cell-derived therapy, we will dually incorporate inducible
safety switches that will allow for small molecule-driven clearance of residual pluripotent cells following beta cell
differentiation, as well as clearance of the entire graft in the instance of an adverse event. These approaches will
be vetted by transplanting engineered stem-cell-derived beta cells into immunodeficient mice that have induced
diabetes, to directly assess the disease-modifying activity of these implanted cells in a physiological context.
Ultimately, this work will advance the therapeutic potential of beta cell transplantation and address the major
current clinical bottlenecks that prevent stem-cell-derived beta cell therapy from becoming a universal treatment
strategy for diabetes.

Public health relevance
Project Narrative Our proposal aims to develop a safe, effective, and retrievable alternative extra-hepatic site for the transplantation of stem-cell-derived beta cells. Building on prior work demonstration that co-transplantation of parathyroid tissue with adult donor islets improves survival and engraftment at an intramuscular injection site in mice, we will introduce factors uniquely expressed by parathyroid gland into stem-cell-derived beta cells using genome engineering strategies. Furthermore, we will also incorporate inducible safety switches that will allow small molecule-driven clearance of residual pluripotent cells following beta cell differentiation, and clearance of the entire graft in the instance of an adverse event.